A Phase II Clinical Trial in Newly Diagnosed Glioblastoma Patients Treated with WP1066 and Radiation

SUMMARY
The brain tumor microenvironment (TME) is dominated by myeloid cell infiltrates which are mostly brain resident
microglia and infiltrating glioblastoma-associated myeloid cells (GAMs). Despite this fact, most clinical trials for
glioblastoma have been directed to T cell-based immunotherapies, which have failed to impact outcome for most
patients. Targeting glioblastoma based on re-education of GAMS to enable immunological clearance is the goal
of this clinical trial. The signal transducer and activator of transcription 3 (STAT3) is a negative regulator of both
innate and adaptive immunity and this pathway is markedly up regulated in the TME. We have previously
developed and tested, in the context of Phase I clinical trials, a first-in-man blood-brain-barrier penetrant small
molecule inhibitor of STAT3, designated WP1066. The Phase I trial results have shown that WP1066 is well
tolerated and is inhibiting the STAT3 target in immune cells. As a monotherapy, WP1066 treatment has
demonstrated the ability to stimulate robust anti-tumor response in multiple preclinical studies that is further
enhanced with radiation therapy, which is standard of care for newly diagnosed glioblastoma and is known to
increase tumor immunogenicity. Unbiased nanostring analysis of treated tumors revealed that activation of
antigen presentation in the TME with the combination treatment. For the research proposed here we want to
extend our preclinical findings to newly diagnosed glioblastoma patients. In this clinical trial, we will test the
hypothesis that the administration of WP1066 with radiation will induce T cell-dendritic cell cluster interactions in
the glioblastoma microenvironment, and this induction, in turn, will increase progression free survival (PFS) for
glioblastoma patients. In specific Aim 1, we conduct a Phase II trial with an expansion cohort for the combination
of WP1066 and radiation in newly diagnosed MGMT unmethylated glioblastoma patients. In cohort 1, newly
diagnosed MGMT unmethylated, IDH1 wild-type glioblastoma patients will be treated with 8 mg/kg of WP1066
while undergoing standard-of-care radiation therapy at a daily dose of 2 Gy. PFS will be used to ascertain if there
is indication of treatment benefit. In cohort 2, patients for whom gross total resection was not achieved will be
treated with the combination of radiation and WP1066 with the intent of obtaining treated tumor, if a surgically
amenable lesion is present. Such tissue would allow for analysis of TME immune activation and cluster
interactions, drug concentrations and target engagement in Aim 2. Aim 2 will also use longitudinal textural MRI
analysis to correlate inflammatory responses in the TME by using our STAT3-specific multiplex immune
fluorescent panel and complementary ex vivo flow cytometry and nanostring profiling. STAT3 target inhibition,
including within specific immune cell populations, will be ascertained through use of the multiplex panel, which
will also inform regarding the induction of cluster interactions in the tumor. HPLC quantification of WP1066
concentrations in both enhancing and non-enhancing tumor will be used to determine drug pharmacokinetics. In
Aim 3, we will clarify which human GAMs in the TME trigger T cell activation, and if such activation is altered by
STAT3 inhibition.

Public health relevance
Project Narrative Reprogramming of predominant immune suppressive innate immunity may allow for immunological clearance of glioblastoma. In a Phase II clinical trial, a blood brain barrier penetrant modulator of a key hub of gliomagenesis and immune suppression, the signal transducer and activator of transcription 3, is combined with standard of care radiation to trigger immune activation within the tumor microenvironment.